Metabolic Studies of Mouse Models of Obesity and Diabetes

The following projects have been supported by Mouse Metabolism Core in FY 2021: 1. DK075021 Role of G protein-coupled receptors in regulating glucose and energy homeostasis Principal Investigator: Hans Jurgen Wess (LBC, NIDDK) 2. DK043313 Role of the Gnas Gene in Metabolic Regulation Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 3. DK043315 Role of Gs-alpha in central regulation of energy and glucose metabolism Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 4. DK043316 Role of Gs-alpha in regulation of adipose tissue growth and function Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 5. DK043317 Role of Gs-alpha in regulation of skeletal muscle metabolism Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 6. DK043318 Role of Gs-alpha in pancreatic islet cell growth and function Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 7. DK075056 Role of Gq/11-alpha in metabolic regulation Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 8. DK031117 Development of drugs acting at adenosine receptors Principal Investigator: Kenneth A Jacobson (LBC, NIDDK) 9. DK075057 DEOB Physiology and pharmacology of BRS-3 (Bombesin Receptor Subtype-3) Principal Investigator: Marc L. Reitman (DEOB, NIDDK) 10. DK075062 Pharmacologic approaches to the treatment of obesity Principal Investigator: Marc L. Reitman (DEOB, NIDDK) 11. DK075063 What can body temperature tell us about energy homeostasis? Principal Investigator: Marc L. Reitman (DEOB, NIDDK) 12. DK075064 Role of brown adipose tissue (BAT) in energy balance Principal Investigator: Marc L. Reitman (DEOB, NIDDK) 13. DK055106 Transforming growth factor - beta superfamily signaling in diabetes and obesity Principal Investigator: Sushil Rane (DEOB, NIDDK) 14. DK055107 Cell cycle regulators in diabetes and obesity Principal Investigator: Sushil Rane (DEOB, NIDDK) 15. DK075013 Nonalcoholic steatohepatitis: natural History, pathogenesis and therapy Principal Investigator: Yaron Rotman (LDB, NIDDK) 16. DK043304 Mechanism of G Protein Beta5/ R7-RGS Protein/ R7BP Complex Signal Transduction Principal Investigator: William F Simonds (MDB, NIDDK) 17. DK075088 Investigating addictive/compulsive feeding behavior Principal Investigator: Michael J Krashes (DEOB, NIDDK) 18. DK054508 Regulation of hepatic and systemic immune responses Principal Investigator: Barbara Rehermann (LDB, NIDDK) 19. DK025061 Receptor Mediated Erythropoietin Metabolic Response and Gender Specific Activity Principal Investigator: Constance T Noguchi (MCB, NIDDK) 20. BC005708 Xenobiotic receptors Principal Investigator: Frank J Gonzalez (LM, NCI) 21. BC011168 Physiological and pathological functions of E3 ubiquitin ligase SMURF. Principal Investigator: Ying Zhang (LCMB, NCI) 22. BC011828 Mitochondrial metabolism in normal and transformed cells Principal Investigator: Natalie Porat-Shliom (TGMB, NCI) 23. HD000642 Molecular Genetics of Adrenocortical Tumors and Related Disorders Principal Investigator: Constantine A Stratakis (PDEG, NICHD)